UDCA AND BILE COMPOSITION AND CYCLOSPORINE ABSORPTION IN LIVER TRANSPLANTS

To determine if UDCA improves cyclosporine absorption, increases bile flow, and alters cell surface HLA expression cytokine activation in patients following hepatic transplant.